Molecular Mechanisms and Regulation Networks of TRPM8

PROJECT SUMMARY/ABSTRACT
Overview of Research: The Van Horn lab primarily focuses on elucidating and understanding the molecular
mechanisms that underlie membrane protein function in health and disease. To achieve these goals, the
laboratory employs a modern state-of-the-art and interdisciplinary approach using biophysical, structural,
computational, and functional techniques. We are experts in membrane protein biophysics and make use of
advanced NMR studies combined with functional whole-cell patch-clamp electrophysiology. These orthogonal
data are linked with Rosetta-based computational techniques to understand protein function. Our primary target
is the TRPM8 ion channel which was initially identified as an oncogene that is prognostic for some types of
cancer progression. More recently, it has become a focus for therapeutic intervention in pain and obesity.
Complicating the potential application of TRPM8 therapies is that it is a molecular integrator that is activated by
a number of diverse stimuli. For example, TRPM8 is the primary human cold sensor but is also activated by the
chemical menthol from mint, both of which activate TRPM8 signaling networks. The ability to respond to several
different stimuli in a polymodal manner makes TRPM8 studies crucial to delineate the independence and
interdependence of molecular mechanisms that result in biological function and complicate its therapeutic
targeting. In addition to direct stimulation by cold and menthol, TRPM8 is regulated by diverse proteins, including
the membrane protein, PIRT, which in turn modulates TRPM8 activation by cold, menthol, and other stimuli.
Beyond our research on direct activation of TRPM8 by cold and menthol, we focus on determining the
mechanisms whereby PIRT modulates TRPM8 function. This has led to a number of contributions from our lab
including, biophysical and structural characterization of TRPM8 and PIRT, TRPM8–PIRT complex stoichiometry,
identification of species-dependent regulation, and central insight into molecular regulatory mechanisms. These
efforts have led to strong scientific output, including publications, seminars, and patents.
Five-year Goals: Broadly defined, we will identify how TRPM8 is directly activated by cold temperatures and
other stimuli, map the allosteric networks that allow for polymodal function, and determine structures of TRPM8
and related membrane protein complexes of functional consequence.
Research Vision: In the past 8 years, there has been an explosion of TRP channel structural biology with now
~100 discrete TRP channel structures. This represents tremendous development and output. Our research
seeks to extend and complement the structural momentum to delineate fundamental mechanistic properties such
as allostery, dynamics, and protein complex regulation that determines function. These TRPM8 outcomes are
anticipated to have direct impacts on human health and disease but also to serve as a template that defines and
identifies fundamental rules and properties of membrane protein function.

Public health relevance
PROJECT NARRATIVE The TRPM8 ion channel protein has emerged as a promising drug target for diverse diseases including many types of pain; however, we currently understand relatively little about its function at the molecular level. This proposed research sets out to illuminate the mechanisms and networks that underlie TRPM8 function. The outcomes of this research will help us better understand normal human physiology, general fundamentals of membrane protein function, and contribute information that will be helpful in guiding future TRPM8-based drug discovery efforts.